RECOMBINANT VACCINIA-HIV ENVELOPE VACCINE IN COMBINATION WITH A GROUP OF SUBUNIT

Use of vaccine combinations to the HIV envelope with an attempt to improve immunogenicity as defined by functional neutralizing antibodies to homologous and heterologous isolates of HIV-1. The study is targeted to vaccinia-naive individuals.